22nd International Vascular Biology Meeting

PROJECT SUMMARY
Since its inception in 1980, the International Vascular Biology Meeting (IVBM) has been a time-honored and
profoundly impactful biennial event. This meeting provides a unique opportunity for the global community to
exchange and discuss new scientific discoveries, and to chart innovative and collaborative future scientific
directions in vascular biology. The IVBM has also served to foster the next generation of scientists in vascular
medicine. IVBM 2022 (October 13-17, 2022 in Oakland, CA) will cover a broad spectrum of vascular biology,
prioritizing emerging areas of research. The vasculature impacts every organ system in development, aging, and
disease and is critical to processes of regeneration. Blood vessel walls regulate multiple physiological functions,
including vasomotor tone, leukocyte trafficking, innate and acquired immunity, permeability, stem cell
differentiation, regeneration, and new blood formation. Abnormalities in any of these functions lead to disease.
Beyond traditional vessel wall pathologies such as atherosclerosis and hypertension, the vasculature contributes
to cancer, neurological disease, diabetes, hematological and immunological disorders, aging, and infectious
processes, most recently COVID-19. Mounting evidence suggests that many COVID-19 symptoms are due to
the virus attacking the vasculature. Advances in vascular biology have led to the development of many new
therapies and preventive strategies with broad impact including those mitigating tumor growth and restoring
vision. IVBM 2022 will provide a timely forum to exchange new knowledge in the rapidly expanding field of
vascular biology, facilitate cross-disciplinary collaboration and critical interactions between seasoned
investigators and trainees, and promote awareness of diverse vascular beds in health and disease. Our objective
is to ignite novel areas of research between academia and industry, and from basic to translational research and
clinical medicine, with the ultimate goal of improving human health. IVBM 2022 is being organized by the North
American Vascular Biology Organization (NAVBO), an organization with a strong track record of promoting
trainees and junior faculty. A significant number of oral presentations are reserved for junior scientists to promote
their career growth. NAVBO is committed to diversity and equity within and beyond the vascular biology
community; the IVBM organizers and speakers include women, junior faculty, underrepresented groups, and
scientists from around the world. We selected the diverse city of Oakland, CA as the conference site. Our
program facilitates cross-fertilization of scientific insights related to different vascular beds (brain, heart, lung,
kidney, liver, and eye) and diverse disciplines (cell biology, genetics, imaging, bioengineering, mathematics,
physics, systems biology, translational research, and drug discovery). By promoting such interactions, we will
generate new basic knowledge of developmental and disease processes, catalyze innovation, and expedite
development of new diagnostic, regenerative and other therapeutic approaches. By engaging young
investigators and fostering diversity we will enrich the field of vascular biology and secure its future.

Public health relevance
PROJECT NARRATIVE The 22nd International Vascular Biology Meeting provides a forum through which diverse trainees and senior investigators from the US and around the world can exchange knowledge about cutting-edge research in vascular biology. IVBM 2022 enhances diversity, is inclusive and provides attendees with an opportunity to interact with each other in non-didactic formats with the goal of providing/receiving career advice and fostering new collaborations. By promoting the exchange of information on multiple levels, the meeting will lead to the development of novel and improved strategies for treatment of vascular pathologies, diseases with a vascular component, and COVID-19 with vascular involvement in a broad context.